TWEAK-Fn14 regulation of non-canonical NF-kB signaling in chronic renal inflammation

ABSTRACT
An estimated 37 million people in the United States suffer from chronic kidney disease (CKD), which is
characterized by steadily declining kidney function due to constitutive inflammation, fibrosis, and tubular atrophy.
Current therapeutic approaches are only able to slow CKD progression. Thus, new therapeutic approaches for
CKD are urgently required. The NF-
associated with inflammation. However, while canonical NF-
compounding evidence that non-canonical NF-
response
kB family of transcription factors is a well-known signaling pathway that is
kB signaling has been intensely studied, there is
kB signaling plays a key role in supporting sustained inflammatory
. Tumor necrosis factor (TNF)-related weak inducer of apoptosis (TWEAK) and its receptor fibroblast
growth factor-inducible 14 (Fn14, also named TNFRSF12a) are among the few identified regulators of non-
canonical NF-
kB signaling.
Studies have shown that TWEAK-induced non-canonical NF-
kB signaling is elevated
in models of kidney disease and activates proinflammatory cytokines and chemokines in response to acute and
sustained kidney injury. Despite the significant progress that has been made in recent years in understanding
non-canonical NF-
kB signaling, there remains a significant gap in our knowledge of how downstream signaling
mechanisms switch to divergent pathways in response to TWEAK stimulation, and less is known about how
TWEAK works in synergy with more well-known cytokines such as TNF
hypothesis of this proposal is that TWEAK-induced non-canonical NF-
unique inflammatory signature when compared to TNF
to: 1) Identify how TWEAK activates non-canonical NF-
by canonical NF-
α and IL-6 in renal cells. The central
kB signaling in renal cells stimulates a
α-driven canonical NF- kB signaling. This proposal seeks
kB in renal cells
kB activators; 2) Determine distinct signatures of RelA and p52 transcription factor activity and
and how these responses are modulated
immune response in cisplatin treated Fn14 knockout mice; and 3) Engineer and validate a cell assay that reports
both canonical and non-canonical NF-
kB signaling in real time for high-throughput screening (HTS) of TWEAK-
FN14 modifiers and inhibitors. The anticipated outcome of this proposal is that we will define key components
that differentiate canonical from non-canonical NF-
kB signaling, and we will develop a novel screening assay
that will be a useful tool in furthering our understanding of chronic inflammation in renal cells. While other studies
focus on TNF
α and more well-established cytokines, this proposal addresses a significant gap in our knowledge
on the interplay between NF-
kB signaling pathways and more specifically, how non-canonical NF-
kB signaling
works in concert to modulate inflammation.

Public health relevance
PROJECT NARRATIVE Failure to resolve acute or recurrent kidney injury can result in the production of proinflammatory cytokines that promotes an environment favorable to the progression of chronic kidney disease (CKD). Current therapies for patients with CKD have only been shown to slow CKD progression. This project proposes to determine the mechanisms and modifiers of TWEAK mediated non-canonical NF- new kB signaling in renal cells to identify therapeutic approaches for targeting inflammation in CKD.